DISSEMINATION

The IMR frequently gives extensive tours of its facilities to various groups, including visiting scientists, university classes, and high school field trip participants. This project is designed to keep track of these various activities and the IMR staff time spent on them. In addition to tours, web page statistics and other dissemination activities will be included in this project.